CORE--BIOSTATISTICAL SUPPORT

This role of this core is to provide biostatistical support to the research projects on this grant, including study design and sample size calculation, randomization procedures, data summarization, statistical programming, and analysis and reporting. Such support will be provided to all of the projects in the program project. The staff of this core work within the Clinical Statistics Department of the Clinical Research Division, which supports centralized data collected post-discharge by the Long-term Follow-up unit.